EFFECT OF CARBOHYDRATES AND AEROBIC EXERCISE ON WEIGHT REDUCTION

This study will investigate the effect of dietary carbohydrate and aerobic exercise in a 2X2 design on body composition, energy expenditure, insulin secretion and catecholamine excretion in obese subjects receiving a hypo-caloric diet.